AGS/AGING Learning, Educating, And, Researching National INitiative in Geriatrics (“LEARNING”) Collaborative

PROJECT SUMMARY/ABSTRACT
The American Geriatrics Society (AGS) and the Health Care Systems Research Network (HCSRN)-Older
Americans Independence Centers (OAICs) AGING (Advancing Geriatrics Infrastructure and Network Growth)
Initiative, funded by the National Institute on Aging (NIA), are partnering to create an AGS/AGING Learning,
Educating, And, Researching National INitiative in Geriatrics (“LEARNING”) Collaborative to fill educational
and training gaps in multiple chronic conditions (MCCs) research. The AGS is the leading organization of
ageriatrics health professionals in the United States and has extraordinary depth of expertise in development
and dissemination of educational programs. The HCSRN-OAICs AGING Initiative is a highly productive,
collaborative, interdisciplinary endeavor involving scientists from 18 HCSRN research centers, in partnership
with investigators from 13 premier, university-based centers established by the NIA (the OAICs or “Pepper
Centers”). The overarching goal of the proposed AGS/AGING LEARNING Collaborative is to develop a
national self-directed learning curriculum focused on the science of MCCs. Through the AGS/AGING
LEARNING Collaborative, we will design, implement, and widely disseminate an innovative, multi-disciplinary,
clinical and translational geriatrics-relevant research curriculum to reach emerging clinician and translational
investigators (T2-T4). The AGS has extensive networks that will allow us to reach institutions that are under-
represented in NIH research funding and enhance recruitment of under-represented minorities into careers in
academic research. The curriculum will encompass: (1) research on the prevention and management of
MCCs; (2) the development and incorporation of function and other patient-valued outcomes into clinical trials;
(3) the recruitment of diverse populations into clinical research; (4) research approaches to the study of
geriatric health disparities; and (5) patient and caregiver engagement in research design, implementation, and
evaluation. Our specific aims are to: (1) Develop a multi-disciplinary online curriculum with a focus on training
new and emerging investigators to conduct clinical and translational research on the prevention and
management of MCCs across the lifespan; (2) Offer train-the-trainer sessions, at the AGS Annual Scientific
Meeting, to introduce the curriculum to clinical and translational scientists for use in teaching at their own
institutions, and meetings and conferences that bring investigators together; (3) Establish a virtual Learning
Community of clinical and translational scientists to promote discussions of innovative solutions to the
challenges of conducting research focused on the prevention and management of MCCs including those
relating to recruitment of diverse populations; (4) Disseminate the curriculum through national research
networks, collaboratives, and professional societies and organizations; and (5) Assess the overall impact of the
LEARNING Collaborative through a quantitative analysis of network reach and impact, and a qualitative
analysis of learner feedback on the curriculum itself.

Public health relevance
PROJECT NARRATIVE We propose a partnership between the American Geriatrics Society (AGS) and the NIA-funded AGING Initiative to create an AGS/AGING LEARNING Collaborative to fill educational and training gaps in multiple chronic conditions (MCCs) science. These efforts will ultimately foster research that will translate into the delivery of higher quality care for the growing population of Americans with MCCs.